Intercellular junctions and cell polarity

All epithelial cells are interconnected through three major types of junctions – Tight Junctions (TJs), Adherens
Junctions (AJs), and Desmosomes (DSMs). In simple epithelia, these junctions are positioned along the apical
end of the cell lateral membrane, where they form the Apical Junctional Complex (AJC). AJs and DSMs, but
not TJs, are also present along the basolateral plasma membrane, where they are much smaller in size. This
asymmetry of junction organization is a distinctive architectural feature of simple epithelia. Such asymmetry is
controlled by a set of conserved polarity proteins. The main question that we set out to address in this proposal
is: how are two polarity proteins, basolateral protein Scrib and apical protein Par3, interconnected with proteins
regulating the positioning of the cell-cell junctions in AJC.
Our recently published results suggested how Scrib maintains “basolateral identity” of simple epithelial cell
membrane, the mechanism that has been elusive for many years. We found that this function of Scrib is based
on regulation of two enzymes, phosphatase PP1 (PP1) and Rho/Rac Guanine Nucleotide Exchange Factor,
GEF-H1. Our results suggest that Scrib holds PP1 in inactive state and releases it in an active form through
interactions with other polarity proteins, Llgl, Dlg, and Band 4.1. We also show that a protein that links the
polarity apparatus with DSM assembly is an ARM protein, plakophilin 3 (Pkp3). We provide evidence that this
protein is stored around TJs in a “dormant” pool that is established under control of the apical polarity protein
Par3. The active form of Pkp3, released from this pool, drives formation of DSMs using the mechanism that is
radically distinct from the assembly mechanism of the evolutionary related junctions, AJs. Furthermore, we
present some evidence suggesting that a similar Pkp-dependent mechanism of junction assembly is involved
in formation of a previously unrecognized subtype of AJs, which we call here Pkp4-dependent AJs. The
advances made in previous years allow us to come up with this proposal, which includes the investigation of:
(i) how Scrib regulates PP1 and what are the effectors of this pathway; (ii) how Pkp3 regulates adhesion
activity of desmosomal cadherins and how its DSM assembly activity is regulated by the polarity system; and
(iii) how Pkp4 controls adhesion activity of classic cadherins in assembly of specific subset of AJs. This work
will pave the way toward the development of reagents modulating the adhesive and barrier properties of
epithelial tissues.

Public health relevance
PROJECT NARRATIVE Apicobasal cell polarity is a unique process that generates an extraordinary diversity of epithelia through regulation of cell- cell junctions and the cytoskeleton. How polarity proteins direct spatial organization of different types of cell-cell junctions is a general subject of this proposal. It will uncover the role and mechanisms that are based on polarity proteins of Scrib and Par3 families in organization of two junctional structures Adherens Junctions and Desmosomes. The role of plakophilin family proteins, Pkp2, Pkp3, and Pkp4, in these processes is also under investigation. The study is a critical step toward the development of synthetic modulators of cell-cell adhesion and their application in medicine.